Structure and function of Transient Receptor Potential Channels

PROJECT SUMMARY
Transient Receptor Potential (TRP) channels represent polymodal cellular sensors, which integrate chemical,
temperature, mechanical stress and membrane voltage stimuli and convert them into ionic currents to regulate
our senses of vision, hearing, taste, smell and touch and contribute to the perception of temperature and pain.
TRP channels are implicated in the pathogenesis of numerous human diseases, including cancers, and
represent one of the most ardently pursued drug targets. Despite recent successes in TRP channel structure
determination, understanding of their genetic diversity, function and regulation is still far from being complete.
Such limited knowledge represents a critical barrier to devising therapeutic strategies based on TRP channel
regulation and to the progress in the rational drug design. We plan to study TRP channel structure and function
using a combination of different biophysical and biochemical methods. Our specific aims are: 1) establish
molecular bases of TRPV6 polymorphisms and disease variants, 2) determine structural mechanisms of TRPV6
inhibition, and 3) identify structural elements underlying similarities and difference in gating and regulation of
TRPV6 and other TRP channels. TRP channels are challenging targets for structure-functional studies because
they represent multimeric integral membrane proteins of a large size with typically low expression levels. To
achieve our goals, we will use a combination of structural and functional approaches, including modern cryo-
electron microscopy (cryo-EM), X-ray crystallography, protein engineering, Fluorescence-based Size Exclusion
Chromatography (FSEC), calcium imaging, fluorescent spectroscopy and electrophysiology. We will express
TRP channels, their mutants and genetic variants in eukaryotic cell lines, purify them using different membrane
mimetic systems, and determine cryo-EM and crystal structures in the presence of different stimuli. We will then
combine the nascent structural information with functional data to discern molecular mechanisms of TRP channel
gating, inhibition and regulation by Ca2+, temperature and lipids. Achieving our aims will significantly improve
understanding of TRP channel structure and function, resulting in a new dynamic template for theoretical
prediction, in silico fitting and chemical synthesis of new drugs.

Public health relevance
PROJECT NARRATIVE Transient Receptor Potential (TRP) channels are regulated by a broad range of stimuli, including chemicals, temperature and mechanical stress and are directly involved in sensory perception such as taste, olfaction, thermal perception and nociception. TRP channels are implicated in the pathogenesis of numerous diseases and some of them represent important prognostic markers and promising targets for new therapeutic strategies to treat a variety of human cancers. Our goal is to study TRP channels using a combination of biophysical and biochemical techniques and to obtain detailed information about their structure and function that will help to develop new drug design strategies.